Genetic and Environmental Risk Factors for Hemorrhagic Stroke – V

3. Project Summary/Abstract
Intracerebral hemorrhage (ICH) is the most severe subtype across the spectrum collectively known as
cerebral small vessel disease (CSVD). Our researchers have previously identified a genome-wide significant
association at the locus Chr1q22 for ICH which replicated in an independent population. This finding was then
replicated in other CSVD phenotypes of white matter hyperintensity, microbleeds and total stroke with a particular
risk for small vessel ischemic stroke. The Genetic and Environmental Risk Factors for Hemorrhagic Stroke
(GERFHS) study then performed deep sequencing of the locus which found that rare and common variants
associated with ICH clustered in the promotor and enhancer regions of a gene labeled polyamine modulating
factor-1 (PMF1). PMF1 is a key transcription factor in the polyamine metabolism pathway. Polyamines are
ubiquitous and our major sources are dietary and from gut microbiota and are posited to have both beneficial
and toxic forms. Thus, our own data and literature support strongly implicates polyamine metabolism may be a
critical and novel risk factor for CSVD.
We further obtained funding to measure polyamine and acrolein levels and found significant differences
between cases and controls as proof of technique and proof of concept data. We further identified a strong trend
of specific ratios of polyamines associated with neuoroimaging correlates of global tractography utilizing
advanced diffusion tensor imaging. Thus, the genomic convergence of common variant, rare variant, RNA gene
expression, protein and metabolomic data identifies polyamine metabolism as a potential novel risk factor for
CSVD and thereby vascular dementia, the second leading cause of Alzheimer’s Disease and Related
Dementias. Our investigators have developed a novel Micellar Electrokinetic Chromatography (MEKC) with
Colinear Laser Induced Fluorescence Detection (LIFD) method to accurately measure both acetylated and
unacetylated forms of each of the major polyamines.
The current proposal seeks to recruit 400 controls from the NIA funded DECADE grant which will have
baseline MRI including DTI along with blood sampling and decades of cardiovascular risk factors in a biracial
cohort. The current proposal will measure polyamines and it’s toxic byproduct, acrolein in the baseline DECADE
sample as well as perform a 36 month-plus repeat MRI with DTI (GERFHS V) and obtain multiple blood samples,
extensive dietary history and cognitive evaluations to evaluate polyamine and acrolein levels and their correlation
with the development of future CSVD. If successful, we will be able to define high risk populations for future
intervention studies as well as target polyamine levels utilizing dietary and/or pharmacologic techniques in future
studies. The proposal extends a 20 year history to identify a novel genetic and environmental risk factor for
hemorrhagic stroke and it’s principal cause, CSVD.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
Narrative. Cerebral small vessel disease (CSVD) is a leading cause of vascular dementia and stroke. We have previously identified a genetic risk factor associated with CSVD which then was confirmed in multiple different manifestations of the disease implicating polyamines as the potential explanation of the association. To prove it, we are measuring levels of the different forms of polyamines and looking at the brain imaging manifestations of CSVD. If positive, there are both dietary and pharmacologic interventions that may be used to reduce risk in the future. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page